Suppression of alveolar stem cells by tissue-resident lymphocytes in emphysema

Project Summary/Abstract
Acute exacerbations in chronic obstructive lung disease (COPD) are often triggered by respiratory viral infections
that leads to irreversible decline in lung function. Mechanistic insight into the pathophysiologic link between viral
triggers and loss of lung structural cells could uncover therapeutic modalities to attenuate the frequent
exacerbations in COPD patients that leads to significant morbidity and mortality. This proposal will interrogate
how tissue factors in the lung alters the inflammatory niche associated with viral infections to suppress alveolar
type 2 (AT2) stem cell in emphysema, a subtype of COPD characterized by the loss of alveolar epithelium. Our
preliminary data demonstrate that fibroblast-specific deletion of Hhip, an emphysema susceptibility gene,
promotes the accumulation of T cells with tissue residency features (tissue resident lymphocytes, or TRLs) in the
alveoli and subsequent loss of AT2s after viral infections, suggesting that host factors in the lung can alter the
inflammatory cascade after viral infections to suppress a lung stem cell reservoir. We go on to demonstrate that
TRLs can directly suppress the self-renewal capacity of AT2s, which is in part mediated by the secretion of the
antiviral cytokine, interferon gamma (IFNγ). Finally, we show that a highly clonogenic human AT2 subset
characterized by basal interferon gene expression is lost in the lungs of emphysema patients concurrent with
accumulation of TRLs. Utilizing a combination of novel genetic tools to trace and delete Hhip+ stromal cells,
genetic model of IFNγ activation, human organoid platform, 3D high-content tissue imaging, single cell analysis
of human lung stem cell subsets, and a novel pharmacologic reagent made in our lab to target TRL
accumulation, this proposal will determine the mechanism by which stromal factors in the lung modifies TRL
accumulation in response to viral infections and tobacco smoke, and how TRLs suppress AT2s in both mouse
and human models. Furthermore, we will determine whether host factors that modify TRLs can be leveraged as
pharmacologic therapy to attenuate the inflammation and stem cell loss associated with acute exacerbation in
emphysema.

Public health relevance
Project Narrative Patients with COPD/emphysema are particularly susceptible to viral infections that increase lung inflammation, leading to worsening lung function and shortness of breath. This proposal will explore how the lung controls the inflammation caused by viral infections, and whether this inflammation is linked to the loss of lung stem cells. Furthermore, we will test new therapy that could potentially treat the inflammation and preserve lung stem cells in COPD/emphysema.